Study to Understand Participant Perspectives On Respite upTake (SUPPORT)

ABSTRACT
Over 6.9 million people are living with Alzheimer's Disease (AD) and Alzheimer's Disease Related Dementias
(ADRD) in the U.S., many of whom rely on family caregivers for activities of daily living. Caregiving to adults with
dementia often requires substantial time commitment and personal attention; over time this can negatively impact
caregiver physical and mental health and wellbeing. Adult Day Services (ADS) offer community or center-based
care for adults with special needs, providing much-needed, temporary relief to family caregivers. ADS is one of
the most affordable care options for adults with dementia, is covered by Medicaid, and is widely available. ADS
offers health benefits for both caregivers and adults with dementia. For caregivers, ADS use is linked to reduced
stress and depression and increased engagement in self-care activities. Among adults with dementia, particularly
those with moderate dementia, ADS benefits include increased social interaction and cognitive health, reduced
sleep disturbances, and delayed entry into nursing homes. Despite considerable need and benefits, estimates
indicate only a quarter of U.S. caregivers to adults with dementia utilize ADS.
Root causes of low ADS use among caregivers have been largely unexplored. Only a handful of studies have
examined determinants of ADS use, with most using national survey data to report disparities in respite care
utilization by race, ethnicity, and income. Little is known, however, about modifiable determinants of ADS use
among caregivers to adults with dementia or perceived barriers and facilitators to ADS utilization from the
perspectives of caregivers, ADS staff, and clinicians. This information is critical to the development of future
interventions to promote ADS awareness, decision-making, and use among caregivers to adults with dementia.
We will address these evidence gaps through our Study to Understand Participant Perspectives On Respite
upTake (SUPPORT). This mixed methods inquiry will leverage two of our team’s ongoing cognitive aging cohort
studies, comprised of 2,000+ patients and involved caregivers in Chicago, IL. For Aim 1, we will augment the
rich data collected as part of these longitudinal studies by asking participants about ADS awareness and use to:
1) Determine the prevalence of ADS awareness and use among caregivers to adults with moderate dementia
and investigate group differences by health literacy and other psychosocial factors. For Aim 2, we will conduct
qualitative interviews with multiple parties to: 2) Examine barriers and facilitators of ADS use from the perspective
of caregivers to adults with moderate dementia, ADS staff, and involved primary care clinicians. This two-year
study is responsive to PAR-23-179 as a small research grant (R03) for the next generation of AD/ADRD
researchers; it also addresses NIA priority areas by identifying key factors driving unpaid caregiver burden.

Public health relevance
PUBLIC HEALTH NARRATIVE Adult Day Services (ADS) offer social activities and temporary care outside of the home for adults with health needs. ADS has been shown to positively impact the health and wellbeing of adults with moderate dementia and their caregivers, yet utilization of ADS is low and the reasons for suboptimal uptake are poorly understood. We will conduct a mixed methods study to identify and investigate root causes of low ADS use from the perspective of caregivers to adults with dementia, ADS staff, and primary care clinicians.